Emory Alzheimer's Disease Research Center

SUMMARY/ABSTRACT: CLINICAL CORE
The primary goals of the Clinical Core are to support and enhance research efforts of the Goizueta Alzheimer’s
Disease Research Center (ADRC) at Emory to advance cutting-edge research to identify novel biomarkers and
therapeutic targets while reducing racial disparities in AD research. The Clinical Core plays a central role in the
Goizueta ADRC by engaging diverse research participants and driving activities that reflect the Center’s overall
themes. To accomplish these goals, the Clinical Core has well-established processes to recruit, track,
characterize, and retain a cohort of longitudinal research participants and to effectively coordinate activities
and share data with other components of the ADRC and external partners. In the current funding period, the
Clinical Core established a Longitudinal Biomarker Collection to support high-priority multicenter research
projects, including the Accelerating Medicine Partnership for AD (AMP-AD) and Molecular Mechanisms of the
Vascular Etiology of AD (M2OVE-AD). Successful development of the LBC led to a competitive supplement to
establish a Biomarker Core which will continue as a Core component in the ADRC renewal. Also, during the
current cycle, we succeeded in our ambitious goal for increasing the diversity of our UDS cohort by enrolling an
equal number of new African-American and Caucasian participants. This success supported the establishment
of a Minority Engagement Core (MEC). Specific Aims for this renewal are to 1) Establish and maintain a
diverse cohort of well-characterized research participants to support priorities in current ADRD research; 2)
Advance biomarker discovery efforts by harmonizing procedures for sample collection and clinical phenotyping
across multiple related projects and cohorts; and 3) Expand and integrate activities in ADRD, including
vascular cognitive impairment and Lewy body diseases. Achieving these Specific Aims will advance the
priorities identified in the National Alzheimer’s Project Act (NAPA) and recommendations from the NIH ADRD
Research Summits, and will ultimately lead to effective diagnostic tools and treatments for individuals suffering
from AD and related disorders.

Public health relevance
Per RFA-AG-20-004 Project Narrative: Do not complete. Note: ASSIST screens will show an asterisk for this attachment indicating it is required. However, eRA systems only enforce this requirement in the Overall component and applications will not receive an error if omitted in other components.